Knowledge and Usage of Lactation using Education and Advice from Support Network (KULEA-NET)

PROJECT SUMMARY/ABSTRACT
Failure to initiate breastfeeding (BF) and exclusively breastfeed (EBF) for the recommended 6-month duration,
can result in long-term morbidity among both mothers and their infants. African Americans/Blacks (AA/B) have
the lowest BF initiation and EBF rates among all racial ethnicities in the US. AA/B infants have
disproportionately high rates of mortality, and children have a high incidence of asthma and sudden infant
death syndrome (SIDS) while AA/B mothers are at high risk for chronic illnesses like obesity, diabetes, and
cardiovascular diseases. These health disparities cost the US more than $9.1 billion in medical treatment
annually but can be reduced by increasing EBF rates. However, AA/B women experience barriers on multiple
levels to initiating, continuing BF, and maintaining EBF (either by discontinuing BF or introducing supplements
BF with other foods). With high rates of smartphone ownership and consumption of digital content in AA/B
women, the proposed mHealth intervention has great potential to increase BF initiation and maintain EBF
among AA/B women and has demonstrated feasibility (user satisfaction and use) in our prior completed
feasibility study. The proposed SBIR Direct Phase II application, Knowledge and Usage of Lactation using
Education and Advice from Support Network (KULEA-NET) addresses an unmet need for an evidence-based
mobile app, providing comprehensive BF support and addresses the interrelated and complex BF barriers
AA/B mothers experience across the socio-ecological layers.
KULEA-NET will provide comprehensive BF support to nurture and support AA/B women in BF initiation and
EBF, and include the following innovative features: a) Social marketing and health branding to promote
EBF as a socially desirable behavior; b) Micro-learning educational content to improve the acquisition of
knowledge and skills related to EBF; c) Support network communication tools leveraging asynchronous
communication that allow mothers to communicate with her BF supporters, peers, and lactation professional
supports; d) Context-aware delivery framework that will capitalize on user information such as date of
delivery, feeding and diaper log data, and location variables to provide timely feedback, content, and guidance;
and e) a Virtual community support network bringing together AA/B mothers and their spouse/family
members, and fostering a community of mutual support.
We hypothesize that KULEA-NET will improve knowledge, BF self-efficacy, and intentions to BF, and ultimately
achieve increased BF initiation, BF duration, and EBF rates at 6 months among AA/B mothers and, as a result,
improved maternal and infant health outcomes.

Public health relevance
PROJECT NARRATIVE The SBIR Direct Phase II project completes the development of KULEA-NET, a mHealth intervention that will improve knowledge, self-efficacy, and intentions related to exclusive breastfeeding (EBF). These factors have been demonstrated to have a positive influence on breastfeeding (BF) initiation and duration among African American/Black (AA/B) mothers. In the long term, KULEA-NET has great potential to achieve increased BF initiation and EBF rates among AA/B mothers and as a result, improved maternal and infant health outcomes.